Mechanisms of Radiation-Induced Innate Immune Dysfunction and Its Countermeasures

PROJECT DESCRIPTION: Nuclear power plant accidents, terrorism, and geopolitical instability present the
risk of massive radiation exposure. As neutrophils markedly decline post-radiation exposure, macrophages
assume the important role of removing most translocated or invading bacteria. However, very few studies
have evaluated the effects of radiation on the phagocytic function of differentiated, non-dividing tissue resident
macrophages. We have discovered that extracellular cold-inducible RNA-binding protein (eCIRP) is a novel
mediator which can cause innate immune dysfunction. In our preliminary studies, we have shown an
increased release of eCIRP after radiation exposure in vivo and in vitro. Deficiency in CIRP improved the
survival of mice subjected to total body irradiation (TBI). Sepsis significantly worsened the survival post-TBI,
but CIRP-/- mice had lower bacterial loads and improved survival after sepsis, suggesting that eCIRP’s
detrimental effect may be due to the impaired bacterial clearance. Indeed, eCIRP significantly reduced
macrophage phagocytosis of E. coli via cytoskeletal paralysis. eCIRP also induced the formation of macro-
phage extracellular traps, and extracellular traps reduced macrophage phagocytosis of dying cells. We have
identified that triggering receptor expressed on myeloid cells-1 (TREM-1) is the eCIRP receptor, and that
TREM-1 activation plays a critical role in the eCIRP-mediated macrophage phagocytic dysfunction. Moreover,
the 30-day survival after TBI was significantly improved in TREM-1-/- mice. Based on these novel findings, we
hypothesize that eCIRP released after ionizing radiation activates TREM-1, resulting in macrophage
phagocytic dysfunction and ultimately leading to sepsis and death. We have also shown that the new inhibitor
M3 reduced eCIRP’s binding to TREM-1 and improved survival after sepsis. As such, we further hypothesize
that inhibition of eCIRP/TREM-1 interaction with M3 restores macrophage phagocytic function, thereby
improving the survival of mice subjected to radiation injury alone or complicated by sepsis. In this project, we
plan to further establish the critical role of eCIRP on radiation-induced macrophage phagocytic dysfunction,
determine the mechanisms by which eCIRP causes macrophage phagocytic dysfunction, and develop M3 as a
novel radiation medical countermeasure targeting eCIRP-induced macrophage phagocytic dysfunction. These
studies shall provide novel mechanistic insights into the pathogenesis of radiation-induced innate immune
dysfunction, as well as a new medical countermeasure for victims of major radiation exposure with or without
sepsis.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT: One of the main causes of death after massive radiation exposure is infection. In this project, we will study the role of a novel protein, extracellular cold-inducible RNA- binding protein (eCIRP), on the reduced removal of bacteria by macrophages after radiation exposure, determine the detailed mechanisms by which this occurs and, importantly, develop a new drug able to revert the eCIRP-induced macrophage defect, thereby attenuating radiation injury and infection. This project aims at establishing the importance of suppressing eCIRP to control infection after radiation injury and developing a new way to protect people from the harmful effects of massive radiation exposure alone or complicated by sepsis.